Request for the Acquisition of a Vevo F2 Ultrasound Imaging System

Project Summary/Abstract
We are applying for funds to purchase the Vevo F2 imaging system from VisualSonics (Fujifilm) to be used
by the investigators at Quillen College of Medicine (QCOM), College of Public Health and College of Arts and
Sciences at East Tennessee State University (ETSU). This imaging system will replace our current ultrasound
system, the Vevo 1100 from VisualSonics (Fujifilm), which is nearly ten years old and is no longer supported
by the manufacturer. The failure of the current system will leave our institution without an ultrasound imaging
system. We currently have many cardiovascular and cancer researchers who use the Vevo 1100 and have
published images acquired on this machine for nearly a decade. The Vevo F2 imaging system boasts new
and updated features compared to the Vevo 1100, which will make the system useful for our eight major and
four minor users across multiple disciplines of heart, vasculature, and oncology research. Features specific
to the Vevo F2 that will be particularly useful to our investigators include HD (high definition) image processing
to generate clearer images, advanced software that includes artificial intelligence algorithms for image
analysis, 4D imaging to enable dynamic changes over time, and cardiac strain analysis. The Vevo F2 imaging
system will primarily be used by NIH-funded investigators, but it will also provide ultrasound imaging access
to junior faculty who are currently seeking NIH funding. The Vevo F2 imaging system will enhance our imaging
quality and speed to make us more competitive in our research efforts. The Vevo F2 imaging system will be
housed in a central location to ensure access to all users. An abundance of institutional support will ensure
the successful use of this imaging system at ETSU. Provisions have been made with the Dean of QCOM, the
Associate Dean of Research and Graduate Education (QCOM), and the Department of Biomedical Sciences
(QCOM) to fund two computers to be dedicated to the Vevo F2 imaging system, a supplemental Vevo analysis
software package, a stipend for our dedicated trainer, salaries of the Principal Investigators and Manager, an
anesthesia system to accompany the Vevo F2, and four years of a service contract with the VisualSonics,
Fujifilm company after the included one-year service contract expires. The Vice Provost for Research and
Chief Research Officer (ETSU) has endorsed the acquisition of the Vevo F2 imaging system. His office will
provide necessary administrative and logistical support for the set-up and maintenance of the new system.
An advisory committee has been established to oversee training, calendar appointments, animal care, and
overall usage of the instrument. Our users would like to stress that no other options for ultrasound imaging
capabilities are available to us at ETSU if the retired Vevo 1100 imaging system goes down. Thus, the Vevo
F2 imaging system would satisfy a significant research need at our institution.

Public health relevance
Project Narrative: This request is for funding the Fujifilm VisualSonics Vevo F2 (animal) imaging system, which will provide multiple users within our university with the opportunity for in vivo ultrasound imaging. This instrument will benefit cardiac, vascular, and cancer biology research at the Quillen College of Medicine, College of Public Health, and College of Art and Sciences at East Tennessee State University. The enhanced and cutting-edge imaging capabilities of this system, compared to the currently available system, will provide our investigators with a reliable tool that will help complete research projects aimed at furthering our knowledge related to human health and disease.